Cell envelope synthesis and antibiotic resistance in Staphylococcus aureus

PROJECT SUMMARY
Staphylococcus aureus is a Gram-positive opportunistic pathogen responsible for life-threatening infections in
hospitals and communities alike. Especially concerning are methicillin-resistant S. aureus (MRSA) strains, which
are resistant to -lactam antibiotics that target cell wall synthesis. Most MRSA strains also carry additional
resistance markers rendering them resistant to multiple antibiotics, so treatment options are limited. Therefore,
there is an urgent need to develop new antimicrobial therapies that are effective against S. aureus. Given that
the cell envelope is the target of our first and best antimicrobials, studies aimed at understanding the mechanisms
responsible for its assembly promise to uncover new vulnerabilities that can be targeted by future antimicrobial
therapies. The proposed research will address two fundamental areas of S. aureus cell envelope assembly and
morphogenesis. First, I address the mechanism by which methicillin-resistance factor PBP2a (a class b penicillin-
binding protein, or bPBP) works with the rest of the cell wall synthesis machinery to promote -lactam resistance.
-lactams like methicillin normally function by inhibiting the transpeptidase activity of bPBPs, which are essential
for forming cell wall crosslinks and resisting turgor pressure. Recent research from my host laboratories and
others has demonstrated that bPBPs act in complex with so-called ‘separation, elongation, division, and
sporulation’ (SEDS) proteins, crosslinking new peptidoglycan polymerized by SEDS proteins into the growing
cell wall. My preliminary results indicate that methicillin-insensitive PBP2a may function by replacing a methicillin-
sensitive bPBP in a complex with the SEDS protein FtsW (the “partner-swapping” hypothesis), restoring cell wall
synthesis in the face of -lactam challenge. Second, I will design and employ high-throughput cytological screens
to identify novel cell envelope biogenesis factors in S. aureus. In spite of the great importance and intensive
study of S. aureus cell envelope, so far it has not been the subject of any such screen. Here, I utilize fluorescence-
activated cell sorting (FACS) to screen a transposon library for envelope biogenesis defects, followed by deep
sequencing of the transposon-genomic junctions of isolated mutants (Tn-seq). This approach has identified many
novel mutants with an enhanced rate of cell lysis and with cell separation defects. Preliminary characterization
suggests that these newly identified factors play roles in chromosome segregation, division site placement, and
cell wall synthesis. The detailed characterization of many of these factors will likely continue beyond the period
of this fellowship to form foundational projects in my own research laboratory, as well as provide potential targets
for future small molecule antimicrobial therapies. The specific aims of this F32 application are to:
AIM 1: Determine how PBP2a integrates into the native cell wall synthetic machinery.
AIM 2: Identify novel factors that function in cell envelope biogenesis using cytological screens.

Public health relevance
PROJECT NARRATIVE Staphylococcus aureus is an opportunistic bacterial pathogen that imposes a serious burden on the healthcare system, particularly methicillin-resistant S. aureus (MRSA) strains, which are resistant to many antibiotics that target cell wall synthesis. Understanding envelope biogenesis in S. aureus is critical to combating pathogenesis in the midst of the rising antibiotic resistance crisis. This project is focused on discovering how known antibiotic resistance factors work in the greater context of cell wall synthesis to promote cell envelope biogenesis in the face of antibiotic challenge, and also on discovering new cell envelope biogenesis factors.